Role of altered gut immune response in Lewy Body Disease

PROJECT SUMMARY/ABSTRACT
Lewy Body Diseases (LBD), which include Parkinson's Disease (PD) and dementia with Lewy bodies (DLB),
represents a spectrum of progressive, debilitating neurological disorders for which there is no cure. Emerging
evidence indicates that for some individuals with LBD and those with prodromal LBD, including those with
isolated REM Sleep Behavior Disorder (iRBD), peripheral organs are involved including the gut. Furthermore,
peripheral insults including alterations to the gut microbiota, immune dysregulation, and toxin exposure have
been implicated in disease pathogenesis. However, few studies have provided comprehensive characterization
of pathologic, immunologic, microbiologic and physiologic parameters in patients with PD or iRBD thereby
precluding definitive conclusions about the role peripheral organs have in pathobiology and disease signatures.
The parent grant, “Role of altered gut immune response in Lewy Body Disease”, included a novel paradigm
whereby the gut microbiome influences neurodegenerative disease through immune mechanisms. We
hypothesized that altered gut neuro-immune interactions, mediated by microbial derived factors, promotes LBD
progression. The parent grant included two Aims: Aim 1 using a multi-modal approach to characterized
peripheral involvement in PD, iRBD and healthy controls and Aim 2 assessing whether the microbiota
promotes LBD by gut immune mechanisms. In addition to our original Aims, the proposed administrative
supplement will add critical neurological and gastroenterological assessments, which have been added to the
Master Protocol for the overall Gut-Brain-Parkinson’s Disease Consortium (GBPDC). Together, in 10 iRBD, 30
PD (10 mild, 10 moderate, 10 severe) and 10 household controls, we propose adding Aim 3 to perform the
following assessments not included in our parent grant: Research Flexible Sigmoidoscopies, Intestinal transit
(Sitzmark), Rectal Balloon Expulsion Time, Anorectal Monometry, and Videofluoroscopic swallowing
study with Penetration-Aspiration Scale, Dynamic Imaging Grade of Swallowing Toxicity, Modified
Barium Swallow Impairment Profile and Functional Oral Intake Scale. In addition, we are adding 15
participant surveys (7 GI, 1 PD motor, 7 PD non-motor), an additional 6-month virtual assessment,
and additional biological samples (screening labs, banked blood, PBMCs, skin biopsy) in the next
year of the study as part of the GBPDC Master Protocol.

Public health relevance
PROJECT NARRATIVE The physical, emotional, and societal costs of Parkinson’s disease will increase over the coming decades as more of us live longer; in fact, the number of people with PD is expected to double in the USA by the year 2040 unless we find safe and effective means to cure, delay onset, or slow progression of these diseases. Non- motor features, including gastrointestinal symptoms like constipation, are a common feature of PD with serious subsequent impact on quality of life and caregiver burden. By determining the interplay between the gut microbiota and immune system, our project is focused on the clear imperative to understand the role of gut health in the pathogenesis of PD.